Inter-Generational Cardiometabolic Risk: Explore Underlying Immune Pathways

Abstract
Despite decades of concerted efforts, the prevalence of obesity and its associated morbidities such as
type 2 diabetes (T2D) and cardiovascular diseases (CVD) continue to climb in the US and racial and ethnic
minority populations living in low-income households and communities are disproportionally affected. Part of
the reason is a well-observed vicious cycle of intergenerational amplification. However, the underlying
pathways driving this cycle remain poorly understood. This proposal aims to explore a novel hypothesis
regarding the role of clinical and subclinical infection and resulting inflammation in the intergenerational
cardiometabolic link. The proposed study is motivated by a strong scientific premise. First, growing evidence
generated by us and others demonstrated that maternal cardiometabolic conditions contribute to child
cardiometabolic risks. This intergenerational link may originate in utero and amplify the cardiometabolic risk in
current and future generations, underscoring the importance of the early life period. Second, there is growing
evidence that infection may lead to both a local and systemic inflammatory state. In the context of maternal-
fetal dyad, maternal infection was found to be associated with increased levels of pro- and anti-inflammatory
cytokine levels in cord blood, independent of vertical pathogen transmission. To date, little is known about
metabolic-immune system crosstalk in early life and health implications. The overarching goal of this project is
to investigate the association of the early life antibody profile to a broad array of pathogenic and commensal
microbes and systemic immunoproteomic profiles in the intergenerational cardiometabolic link. We will also
explore micronutrient status as a protective factor. Specifically, we aim to 1) identify early life immune
response signatures of long-term cardiometabolic outcomes; 2) examine the role of early life immune
responses in the intergenerational cardiometabolic link; and 3) explore the interplay of early life micronutrient
status and immune responses on the intergenerational link of cardiometabolic outcomes. We will leverage the
rich resources of the Boston Birth Cohort (BBC), with ~3,500 mother-child pairs who were enrolled at birth and
followed prospectively. We have shown that the BBC is a high-risk population for adverse cardiometabolic
outcomes. A particularly novel aspect of this study is that we will leverage existing antibody repertoire data
generated by cutting-edge technology (PhIP-Seq) and immunoproteomic profiles generated by the high-
throughput Olink platform at two critical developmental windows: at birth (reflecting the in-utero state) and at
age 1-2 years (reflecting early life immune response). Successful completion of this study will help to deepen
our understanding of the immunologic pathways underlying the intergenerational cardiometabolic link, reveal
novel biomarkers and targets, and lead to a new paradigm for early prediction and prevention to halt or reverse
the vicious intergenerational cycle of cardiometabolic disease.

Public health relevance
Narrative We propose to investigate the underlying immune pathway of the intergenerational link of adverse cardiometabolic outcomes by integrating state-of-the-art antibody profiles to a broad array of pathogenic and commensal microbes and systemic immunoproteomic profiles in a high-risk U.S. racially and ethnically diverse prospective birth cohort. Findings from this study may lead to a new paradigm to halt or reverse the vicious intergenerational cycle of cardiometabolic risk, and to improve health across the lifespan and generations.